REPOSITORY SERVICES FOR PULLS AND SHIPMENTS FOR PILOT STUDIES

A vast array of scientific research projects of the Eunice Kennedy Shriver National Institute of Child Health and Human Development have resulted in an extensive repository of human biospecimen collections. The Historic Collection includes that were not actively collecting specimens in 2015. NICHD is interested in encouraging use of these specimens for secondary research. The Institute recognizes that not all stored specimens are ideal for specific types of analyses. Therefore NICHD will provide funding for up to 700 specimens with the goal that these specimens will be used for pilot studies t determine efficacy.